ROD AND CONE SIGNALING PATHWAYS IN MAMMALIAN RETINA

DESCRIPTION (provided by applicant): In this competing renewal application, we propose to continue and extend our investigations on rod and cone signaling pathways at the bipolar cell (BC), amacrine cell (AC) and ganglion cell (GC) levels in the dark-adapted mouse retina. We will focus our efforts to study the BC and AC synaptic circuitries mediating rod, M-cone and M/S-cone signal transmission to three types of alpha ganglion cells (alphaGCs), and to determine how glycinergic and GABAergic ACs regulate light-evoked signals in alphaGCs via the AC cone BC GC feedback pathways and the AC GC feedforward synapses. There are three specific aims: (1) to correlate physiological BC types with anatomical BC types in the three alphaGC circuitries and to identify possible synaptic contacts between rods/cones and BCs and between BCs and alphaGCs; (2) to determine the relative strengths of rod- and cone-mediated inputs to BCs and alphaGCs and mechanisms of signal integration in the 3 alphaGC circuitries by analyzing BCs' and alphaGCs' light-evoked cation currents ( IC) in wildtype, Tralpha-/- and Gnat2cplf3 mice; and (3) to determine relative glycinergic and GABAergic AC contributions to alphaGCs' light-evoked inhibitory and BC synaptic inputs and possible synaptic connectivity between individual GABAergic ACs and alphaGCs by double label and dual voltage clamp techniques. The goal of our research is to understand how mammalian retinal networks process visual images, a basic research priority of the NEI, and to provide crucial information on how individual retinal neurons and synapses dysfunction in disease states, such as congenital stationary night blindness and glaucoma, a translational research priority of the NEI. Moreover, knowledge of specific mammalian retinal circuitries in healthy and diseased eyes will be useful for developing new gene/drug therapies for retinal disorders, such as retinitis pigmentosa and glaucoma, as well as for designing effective retinal prosthetic devices.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of our research is to understand how the mammalian retinal network processes visual information, and how individual retinal neurons and synapses dysfunction in eye diseases, such as retinitis pigmentosa, congenital stationary night blindness and glaucoma. Results obtained will provide a crucial knowledge base for developing new gene/drug therapies against retinal disorders and effective retinal prosthetic devices.